Project 4: Targeting 4EBP1 in glioblastoma

PROJECT SUMMARY
Although signaling from phosphoinositide 3-kinase (PI3K) to the mechanistic target of rapamycin (mTOR)
features prominently in glioblastoma, inhibitors that target PI3K and mTOR have failed in patients with
glioblastoma. In published and preliminary data presented in this application, we identified the mTOR target p-
4EBP1 as a robust biomarker for therapeutic response. We further show that the failure of PI3K and mTOR
inhibitors tested in glioblastoma patients is not because these targets and pathways are unimportant, but
because agents used clinically fail to target 4EBP1. We have now identified and tested a new class of 4EBP1
inhibitors (developed by UCSF collaborator Kevan Shokat) that potently block 4EBP1 in glioblastoma in-vivo,
leading to robust improvement in survival in preclinical orthotopic models of GBM. Our proposal develops this
class of drugs for clinical use, evaluating a clinical 4EBP1 inhibitor, and providing a precision medicine path
forward for a clinical trial in patients with glioblastoma. This clinical agent, Rev1, is available collaboratively
with Revolution Medicines, a company co-founded by Dr. Shokat. While glioblastoma was not initially part of
Revolution Medicine's clinical program, this SPORE incentivizes testing of Rev1 in glioma. We will test Rev1 in
an early phase clinical trial by year 4 for this SPORE. The SPORE mechanism therefore provides a unique
opportunity to test the hypothesis that clinical agents derivatized from RapaLink-1 represent potent clinical
inhibitors of 4EBP1, and will be highly active in relevant subpopulations of GBM. Our specific aims are:
Aim 1. To define the optimal glioma sub-population for clinical trials using inhibitors of 4EBP1
Aim 2. To optimize the efficacy of 4EBP1 inhibitors for clinical development.
Aim 3. To design and conduct a phase IB clinical trial with Rev1 in pathway-activated recurrent
glioblastoma.

Public health relevance
PROJECT NARRATIVE PI3K/mTOR signaling is activated in most glioblastoma tumors. We traced the failure of agents targeting this pathway either to ineffective pathway blockade (failure to block the mTOR target 4EBP1), or to poor in-vivo pharmacology. Our proposal evaluates a clinical 4EBP1 inhibitor that corrects both of these deficiencies, providing a precision medicine pathway for a clinical trial in GBM patients.